Deciphering molecular mechanisms underlying cellular plasticity and metastasis

Project Summary/Abstract Cellular plasticity, a feature associated with epithelial-to-mesenchymal transition (EMT), contributes to tumor cell survival, migration, invasion, and therapy resistance. Across human cancer, tumors that are high grade, poorly differentiated, and have undergone EMT carry a worse prognosis with a high likelihood of metastasizing to distant organs. EMT is a common feature associated with tumor progression and is thought to be critical to cancer cell dissemination in some tumors, such as pancreatic ductal adenocarcinoma (PDA). PDA is a lethal and poorly understood human malignancy that is characterized by an activating mutation in KRAS. Additionally, AXL, a receptor tyrosine kinase (RTK), has been implicated in tumor progression, metastasis, therapy resistance, and EMT in multiple cancer types including PDA. During my dissertation studies, I have found that TANK-binding kinase 1 (TBK1), a critical downstream effector of mutant active KRAS, is central to AXL-driven EMT in KRAS-mutant PDA. However, the mechanism of how TBK1 drives EMT has yet to be elucidated. We hypothesize that TBK1 drives EMT via activation of AKT3 and the stability of downstream transcriptional networks. My data demonstrate that AKT3 is activated downstream of TBK1 in response to stimulation of AXL, which leads to the binding of AKT3 and Slug in an AXL-TBK1 dependent manner. To complete my dissertation, I will establish the function of AKT3 in driving EMT downstream of Axl and TBK1 with the following goals: 1) Establish the necessity of AKT3 for Axl and TBK1 driven EMT; 2) Evaluate EMT transcription factors engaged downstream of TBK1 and 3) Determine the effect of AKT3 activation on the stability of EMT transcription factors. Despite significant evidence that EMT directly contributes to tumor progression, several studies have suggested EMT is not required for the metastatic spread of PDA and breast cancer. For example, most metastatic lesions are known to exhibit epithelial features, an observation that seems to be at odds with EMT as a prerequisite for metastasis. As such, the importance of EMT in cancer biology h as been questioned. I hypothesize that the chronic activation of an EMT program within a tumor may depend on paracrine signals within the tumor microenvironment, dictating whether the tumor cells undergo EMT or MET. Because these cells exist in a plastic state, it is possible that these tumor cells readily revert their phenotype based on a microenvironment-specific context and factors. Additionally, current in vivo lineage- tracing technology has not settled the debate between the importance of collective m igration and/or EMT for metastatic dissemination. During my postdoctoral research, I aim to investigate the role of EMT in metastasis using in vivo lineage tracing, single-cell sequencing, and organoids to better understand epithelial plasticity in an oncogene- and tissue-specific manner. Understanding this process will aid in the development of effective metastatic cancer therapies and will direct future research directions in metastasis.

Public health relevance
Project Narrative TANK-binding kinase 1 (TBK1), a critical downstream effector of mutant active KRAS, is central to Axl- driven epithelial-mesenchymal transition (EMT) in KRAS-mutant Pancreatic Cancer (PDA); however, the mechanism of how TBK1 drives EMT has yet to be elucidated. I hypothesize that Axl-mediated TBK1 drives EMT via direct activation of AKT3 and the stability of downstream transcriptional networks. Despite significant research efforts, the function of EMT in metastasis has yet to be fully elucidated and metastatic cancers and relapse remain the primary cause of cancer related deaths; therefore my postdoctoral studies will be focused on understanding the molecular mechanisms underlying cellular plasticity, EMT, and metastasis to reveal novel strategies to target these programs for effective therapy for metastatic cancer. .